Developing Diagnostic and Therapeutic Strategies to Reduce Hispanic Cancer Disparities Using Genetic, Molecular and Physiological Signatures from Mexican origin Cancer Patients

ABSTRACT
Hispanics are the largest and fastest growing US ethnic demographic, and it is projected that the Hispanic share
of the US population will increase to nearly 30% by 2050. Hispanics suffer from marked cancer health-related
disparities and cancer is the leading cause of death for Hispanics in the US. Despite these considerable cancer
health-related issues, Hispanics are underrepresented in cancer research in two significant areas. First, there
is little research focused on understanding the genetic, molecular, and physiological aberrations in Hispanic
cancer tissue, which may be particularly important for explaining Hispanic cancer health disparities. Second, there
is a lack of availability of cancer tissue from Hispanic patients, a profound barrier for developing targeted
therapeutic interventions. The objectives of the present Research Plan will directly address each of these
deficiencies by establishing the first comprehensive Mexican Origin Cancer Tissue Biorepository and by
developing, for the first time, novel genetic, molecular, and cellular signatures from primarily Mexican origin
cancer patients as platforms to inform diagnostic and therapeutic strategies. Our focus on the Mexican origin
population stems from the fact that the El Paso TX USA/Juárez CH MX borderplex is one of the most dynamic
international borders in the world, with a population of more than 2.5 million residents. In El Paso County, TX
82% of residents are Hispanic, 96% of whom are of Mexican origin. The proposed studies will test the novel
HYPOTHESIS that the reduction and elimination of cancer health disparities in Mexican origin individuals is
dependent on identifying, understanding, and therapeutically-targeting the unique molecular, genetic and
physiological signatures of cancer from these patients. Specific Aim 1 is focused on establishing the first
comprehensive Mexican Origin Cancer Tissue Biorepository at The University of Texas at El Paso (UTEP)
through our established collaborations with area hospitals in El Paso and Ciudad Juarez CH MX. This will allow
local investigators access to Hispanic cancer patient samples for investigative purposes. Specific Aim 2 will
address the fact that Hispanics are underrepresented in cancer research and clinical trials. Clinical observations
such as poor survival may be attributed to a lack of unknown genetic abnormalities. Therefore, we propose to
perform the first FDA-approved drug assay with comprehensive multiplex proteomic analysis and Whole Exome
Sequencing (WES) on patient samples obtained from the Mexican Origin Biorepository. Specific Aim 3 will
develop the first diagnostic tools using molecular, multi-omics, and bioinformatic approaches to address the
growing incidences of liver and prostate cancer within the Hispanic community. The current research findings will
exert a sustained and powerful influence on the field by providing novel insight and direction for reducing the
deleterious effects of cancer in Hispanics of Mexican origin, and will establish The UTEP BBRC and the El
Paso/Juarez borderplex as critical drivers of Hispanic cancer health disparities research.